Stanford Medicine Center for Longevity and Healthy Aging Leadership & Administrative Core

REVISED PROJECT SUMMARY—LEADERSHIP AND ADMINISTRATIVE CORE
The Stanford Medicine Center for Longevity and Healthy Aging brings together a variety of scientific
and medical disciplines to advance research by integrating biological, social and behavioral and
cultural aspects using various innovative techniques including emerging methodologies (biomedical
data science, digital health methods, precision medicine techniques and virtual reality and simulationbased
interventions), qualitative research, mixed methods research and implementation science. The
primary focus of the Leadership and Administration (LAC) core is to implement mechanisms and
procedures for (i) timely communication, collaboration, and synergy across the center and our
institutional partners; (ii) metric-driven evaluation, including tracking the productivity of our center; (iii)
financial management and administrative support; (iv) oversight of the pilot award program; and (v)
oversight for data safety, and monitoring procedures in compliance with institutional and federal
regulations. The LAC core will guide, coordinate, and facilitate best practices of the other cores’
activities, ensuring timely and ongoing cross-core communications to achieve the collective aims. An
Executive Committee will be responsible for the overall scientific and administrative goals and
objectives. The LAC core will receive oversight, input, and support from the External Advisory
Committee. By providing an integrated infrastructure for the logistical and management requirements of
the center components, the LAC will increase productivity, enhance efficiency, and promote unified
efforts toward achieving the center’s goals.
The Specific Aims of the Leadership and Administration core are to:
Aim 1: Implement mechanisms and procedures to foster and ensure regular and timely communication,
collaboration, and synergy across the entire research consortium.
Aim 2: Maintain and continually improve systems and processes for metric-driven evaluation of the
Stanford Medicine Center for Longevity and Healthy Aging Consortium to ensure efficiency and
productivity of the cores and individual pilot projects, including the tracking of the productivity of our junior
investigators.
Aim 3: Provide financial management and day-to-day administrative support to ensure the efficiency
and productivity of the Stanford Medicine Center for Longevity and Healthy Aging Consortium cores
and individual pilots.
Aim 4: Oversee the pilot award program in collaboration with the REC Co-Leads and support the
Site-PIs at our Resource Limited Institution partners, Palo Alto University and San Jose State
University, in identifying Assistant Professor-level applicants to apply to the research pilot program.
Aim 5: Provide oversight for human subjects, data safety, and monitoring procedures for all pilot
projects to ensure compliance with all institutional and NIH regulations and procedures, particularly the
timely communication with the Institutional Review Board.